Role of the prefrontal cortex in behavioral modulation of basal forebrain activit

DESCRIPTION (provided by applicant): The prefrontal cortex (PFC) is a crucial region involved in goal-directed behavior and top-down modulation of sensory processing. Although much work has been done to study task-related activity in the PFC, the principles underlying its functional organization remain unclear. Here I propose to investigate the intriguing possibility that the functional similarity between PFC neurons is closely related to their shared projection targets, using the PFC projection to the basal forebrain (BF) as a case in point. This pathway is thought to partly mediate PFC's top-down modulation of sensory processing, but this idea still lacks experimental support. Using state-of-the- art retrograde viral tracing techniques, I will firt perform a detailed anatomical characterization of the PFC-BF pathway. The next step will be to combine such techniques with two-photon calcium imaging in awake, behaving mice to identify BF- projecting cells in the PFC and measure their task-related activity, contrasting it with other cell populations within the region. The results will shed light on the functional organization of te PFC, as well as the circuit underpinnings of top-down modulation of sensory processing. Such knowledge is of great potential clinical relevance, given the involvement of PFC and BF in several neurological disorders, such as Alzheimer's disease, schizophrenia, and Parkinson's disease-related dementia.

Public health relevance
PUBLIC HEALTH RELEVANCE: The prefrontal cortex is a crucial region involved in controlling goal-directed behavior. Consistent with this function, it is believed to play a key role in modulating how early cortical regions process sensory stimuli coming from the periphery. However, the neuronal circuits implementing this function remain poorly understood. Using state- of-the-art viral tracing and single neuron imaging techniques in behaving mice, this project will investigate task-related activity properties of neurons in the prefrontal cortex that project o the basal forebrain, another region involved in top-down modulation of sensory processing. The results are expected to reveal some of the general principles underlying the functional organization of the prefrontal cortex. Such knowledge is of great potential clinical relevance, given the involvement of this cortical region and of the basal forebrain in several neurological disorders, such as attention deficit disorder, schizophrenia, Alzheimer's disease, and Parkinson's disease-related dementia.